Portable Hearing Laboratory - CRP

In the parent Phase II project (R44DC016247; PI: C. Pavlovic) we successfully developed a
portable platform for developing and testing new hearing aid technology. This Portable Hearing
Laboratory, or PHL, has now been acquired and is being used by a number of leading university
laboratories and other research centers and their feedback has been extremely positive. The
device features a central unit (BatAndCat Box) which provides an appropriate and complete
hearing aid ambient for developing new algorithms. A number of realistic interfaces has also
been provided. This includes an extremely high quality BTE system we designed; an ITE
system adapted by us, as well as an appropriate interface circuitry for typical wearables (e.g;
headsets via the line input). Finally, a smart phone app features interfaces both for the
researcher and the subject. The system runs the Master Hearing aid sweet developed
concurrently in R01DC015429 (PIs Hohmann and Pavlovic). In this CRP renewal we will
achieve the following goals:
1. Implement various Design for Excellence Measures (DFX) and super modern manufacturing
technology to obtain the highest product quality at the lowest product cost. This would make
the product affordable for large clinical studies and, potentially, for some consumer sales.
2. In response to the recent availability of, and the recent research demand for, a far greater
processing power to enable the development of algorithms which rely on machine learning,
we plan to increase the processing power of the device by at least 10 times, and likely 20
times, by changing the processor core to a multicore system.
3. Introduce modern low-latency BLE technology to enable efﬁcient noise reduction by utilizing
remote microphones and machine learning.
4. The other complementary requirement to extract speech from noise is being able to inform
the system whom the listener is actually listening to. This will be achieved by providing on
the PHL the interface means for external multi-sensor arrays such as EEG, OEG, etc.
5. Execute electrical and mechanical design changes dramatically reducing the size and
weight of the device. This would not only be a much more acceptable device for long clinical
trials, but would also open up a direct-to-consumer, secondary market for the device.
6. It is our strong determination to provide continuous support to the Beta sites for extensive
further testing of the device in a variety of settings. We consider this the best means to
reach the perfection.

Public health relevance
Portable Hearing Laboratory (PHL), developed in R44DC016247 has been deployed successfully at various research centers and it features a central unit connected to a number of realistic interfaces such as BTEs, ITEs, or typical wearables. In this CRP renewal we upgrade the technology to support demanding machine learning algorithms interfaced almost inconspicuously to a number of EEG and EOG electrodes to extract perfectly speech from noise. Simultaneously, we apply modern manufacturing technology to produce small, powerful and low cost devices.